Biomedical Informatics Training Program at Stanford

Project Summary – Parent Award T15 LM007033
For almost four decades, the Stanford Biomedical Informatics (BMI) Program has granted PhD and MS
degrees to graduates who have made significant contributions to biomedicine and health through
data-driven and computationally-derived scientific discoveries and advances. Today our trainees have
access to unprecedented amounts of biomedical data that span our entire biomedical enterprise, and they are
empowered by their training in biomedical informatics and data science to advance the life sciences and improve
clinical care. Our proposal for the future of BMI training at Stanford harnesses the opportunity to produce the
next generation of researchers who will enable precision medicine through innovations in translational
bioinformatics, health care informatics and clinical research informatics. We request annual support for
training 13 pre-doctoral candidates (including two candidates in HIV informatics), 4 postdoctoral candidates, and
4 short-term diversity candidates, for a period of 5 years. Our trainees will benefit from a rich curriculum that
consists of specially-designed core courses in biomedical informatics and data science, technical electives
from companion fields of computer science, statistics, mathematics and engineering, teaching in domains
of biological and clinical sciences, and instruction on the principles of responsible conduct of research
and the methods of rigor and reproducible research. Our trainees will be provided with outstanding mentored
research opportunities from among 34 investigators who collectively represent 16 departments and divisions
across 3 schools at Stanford University. Starting August 2021, our BMI program will benefit from the recent
establishment of the Department of Biomedical Data Science (DBDS) at Stanford, for which it will be the
primary graduate training program. DBDS will serve as a critical nexus to increase the education and research
opportunities for our BMI trainees. Our environment is well-positioned for such expanded opportunities through
a recent explosion of highly successful initiatives including the Institute for Human-Centered AI (HAI), the
Center in Artificial Intelligence in Medicine Imaging (AIMI), and the Center in Digital Health (CDH). In
addition, our training is deeply considerate of issues related to diversity, equity and inclusion (DEI) in
all aspects. Our program has a long track record for diversity recruitment and retention, which we have
expanded through a DEI focus in our curriculum with new course content related to fairness and bias, and
through the creation of new outreach opportunities to applicants. Through these efforts and others, Stanford
University remains a fertile environment for training in biomedical informatics and data to advance human
health.

Public health relevance
Project Narrative - Conference The National Library of Medicine supports research training in biomedical informatics and data science at educational institutions in the United States. These training programs offer graduate education and postdoctoral research experiences in a wide range of areas including: health care informatics, translational bioinformatics, clinical research informatics, public health informatics. Each year an Informatics Training Conference is convened to bring NLM trainees together to showcase their work, to evaluate the full scope of current work in the field, and to meet their peers.